A Prisma Upgrade for the OHSU Advanced Imaging Research Center 3T MRI Instrument

? DESCRIPTION (provided by applicant): The OHSU Advanced Imaging Research Center (AIRC) was established in 2003 to provide access to state-of- the-art instruments and expert technical support in magnetic resonance science to the OHSU research community. The Center now supports four high-end research-dedicated MRI instruments that includes two whole-body 3 Tesla(T) Siemens TIM Trios, a large-bore (90cm) 7T Siemens Magnetom, and a 31 cm bore 11.75T Bruker small animal instrument. Three of the instruments are located on the main OHSU campus located on Marquam Hill, overlooking downtown Portland, and one of the 3T MRI instruments is located at a satellite AIRC facility on the campus of the Oregon National Primate Research Center (ONPRC). Each of these instruments has substantial capability to generate large amounts of data and, in doing so, advance our understanding of the root causes of disease. Ultimately, we expect the magnetic resonance data generated by the OHSU community to play a pivotal role in the development of new methods of prevention, early diagnosis and intervention for many disease states. However, the image quality, temporal resolution and scanning environment necessary to remain productive in this area requires that our 9 year old 3T Tim Trio be upgraded. The subject of this application is to request funds for an upgrade of our current Siemens TIM Trio to the 3T Siemens Prisma instrument. Our current i n s t r u m e n t has been in operation since 2006 and supports more than 30 principal investigators, many with projects funded through federal agencies. The proposed upgrade will provide much needed improvements in gradient performance, data acquisition speed, temporal stability, improved workflow, and post-processing capabilities (data access, image reconstruction, calculation) capabilities that will substantially benefit on-going studies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Funds are requested to upgrade the 3 T M R I at Oregon Health & Science University's Advanced Imaging Research Center. This system is used by a large number of NIH funded investigators to improve public health through the study of several brain ( multiple sclerosis, Alzheimer's disease, autism, substance abuse, and tumors), metabolic (diabetes) and cardiac (hypertrophic cardiomyopathy) disorders. The requested upgrade will accelerate scientific discovery for a growing community of neuroscientists conducting innovative magnetic resonance research at OHSU.